Pulmonary Endothelial-Mesenchymal Crosstalk in Hyperactive mTOR Lung Diseases

Project Summary/Abstract
Pulmonary lymphangioleiomyomatosis (LAM) is a rare lung disease caused by inactivating mutations in the
tuberous sclerosis complex (TSC1/TSC2) gene which results in constitutive activation of the mechanistic target
of rapamycin (mTOR) pathway. LAM manifests with diffuse parenchymal cysts complicated by secondary
spontaneous pneumothorax, chylous pleural effusions and renal angiomyolipoma. In addition, a subset of LAM
patients also develops pulmonary vascular remodeling and pulmonary hypertension. More recently, mTOR has
been implicated in other proliferative pulmonary diseases including chronic obstructive lung disease (COPD),
idiopathic pulmonary fibrosis (IPF) and pulmonary arterial hypertension (PAH). Despite the growing importance
of mTOR activation in pulmonary diseases, the effects of mTOR hyperactivation on pulmonary cells remains
incompletely understood.
To study the effects of mTOR activation on pulmonary vascular remodeling, I will utilize a novel mouse
model with tsc2 deletion as well as single cell RNA sequencing of human LAM lungs. I have found pulmonary
vascular remodeling in the tsc2-null mice that mirrors histopathological findings in human LAM. Moreover, our
lab recently found that LAM cells hijack the lung transcriptome leading to WNT pathway upregulation in the LAM
lung. This proposal will examine how WNT activation in mTOR hyperactivated lungs contributes to pulmonary
vascular remodeling with transgenic mice created by the cross of our novel tsc2-null (mTOR activated) mouse
with Ctnnb1 (β-catenin) WNT pathway-activated mouse lines.
This project will expand my training to include key methods and concepts in cellular crosstalk and signaling.
My training will comprise of individualized mentorship, coursework/workshops in flow cytometry, training in
bioinformatics and animal models. My training will take place under the sponsorship of Dr. Vera Krymskaya, a
leader in LAM research. The Krymskaya lab was the first to establish human LAM cell cultures to demonstrate
efficacy of rapamycin for inhibition of mTORC1 and abrogating LAM cell growth. This work will be conducted at
the University of Pennsylvania, a world-class research institution with a rich intellectual environment,
collaborative investigators and extensive resources for the pursuit of biomedical research. Together, the
research and training plans proposed herein will facilitate a better understanding of the pulmonary
microenvironment and endothelial-mesenchymal crosstalk while preparing me for my future career as an
independent investigator in the field of pulmonary biology.

Public health relevance
Project Narrative Pulmonary lymphangioleiomyomatosis (LAM) is caused by constitutive activation of the mechanistic target of rapamycin (mTOR) growth pathway and manifests with cystic lesions, chylous effusions, and in a subset of cases, pulmonary vascular remodeling. This proposal uses three transgenic mouse lines to investigate the role of constitutive mTOR activation on pulmonary vascular remodeling. The results from this work will help define the role of aberrant mTOR signaling on endothelial-mesenchymal crosstalk and identify mechanisms of vascular remodeling that can be harnessed to provide potential new therapeutic targets.